Morphogenesis: Biophysics and Genetics of Dorsal Closure

Cell sheet morphogenesis is essential for metazoan development and homeostasis of animal form – it contributes
to development, such as in gastrulation, neural tube, heart and palate formation and to homeostasis, in wound
healing. Gene expression and signaling cascades coordinate and regulate the cellular machines that drive
morphogenesis. Disfunction in these components causes developmental and wound healing defects that can
disfigure or kill. We focus on the molecular mechanisms of cell sheet morphogenesis during dorsal closure (DC)
in Drosophila melanogaster. During DC, lateral epidermal sheets advance to close a dorsal opening. We
pioneered the study of DC as a model system and use an unusually diverse repertoire of interdisciplinary
approaches, including live imaging, reverse and forward genetics and biophysical strategies to interrogate the
mechanics and regulation of closure in wild type and mutant embryos. We found that DC is the sum of four major
dynamic processes and is robust and resilient – no single force that drives closure is absolutely required.
Processes that contribute to DC at the molecular, cellular and tissue scales are highly conserved in animal
phylogeny making Drosophila an ideal model system for interrogating the molecular basis of morphogenesis.
There remain significant gaps in our understanding of this conceptually simple, yet biologically complex cell
sheet movement. To identify new “DC genes”, i.e., genes that when deleted, disrupt closure, we initiated a forward
genetic, live-imaging, screen. This screen used 194 deficiency stocks (Dfs) that collectively delete 5,778 of the
5,854 genes on melanogaster's 2nd chromosome. We have begun to extend our screen to the 3rd chromosome.
Remarkably, 96 Dfs caused notable and diverse defects in closure, indicating that a large number of discrete
biological processes contribute to closure and are susceptible to mutational disruption. Thus far, we have
identified 13 new pre-DC or DC genes that are responsible for the DC Df phenotypes. When extended to the whole
fly genome our screen is projected to identify ~165 new DC genes (only ~140 DC genes were known at the start
of our screen). Based on phenotype, we prioritize the DC Dfs on which to focus, identify the DC genes responsible
for their Df phenotypes, then characterize how the new DC gene products contribute to closure. A priority is to
understand the molecular mechanisms by which cell-cell interactions and cell-matrix based adhesion couple to
the actomyosin cytoskeleton – these connections must be robust enough to transmit forces, yet malleable enough
to allow the cell shape changes that define morphogenesis. Of further interest is a new effort to
thermodynamically and kinetically characterize the myosin 2 motor that drives morphogenesis in DC and other
developmental processes. Our goal is to assess how differential splicing that encodes myosin's motor domain
contributes to morphogenesis as a fast moving, slow/efficient force holding, strain sensing, or processive motor.
We are uniquely positioned to address the molecular and biophysical mechanisms that underlie the basic biology
of cell sheet morphogenesis in flies, research that directly informs vertebrate development and wound healing.

Public health relevance
Morphogenesis, the biological process that causes cells or tissues to attain their characteristic shape, is highly conserved throughout phylogeny and is fundamental to development and wound healing. We use powerful imaging, genetic, biochemical and biophysical approaches to investigate cell sheet morphogenesis in a model system, Drosophila melanogaster. Our studies are designed to probe the molecular function of key players in contractility (the motor proteins, myosins) and to identify new genes that regulate and drive cell sheet movements, then investigate the molecular basis for how the genes c0ntribute to such morphogenesis – our work continues to provide important insights into the basic biological mechanisms that go awry in human pathologies such as cardia bifida, spina bifida, cleft palate and wound-induced, epithelial lesions.